Nitric oxide Releasing Ultra-Slippery Antibacterial Surfaces for Urological Catheter Applications

Abstract
Urinary catheters are one of the most widely used medical devices in a hospital setting and are expected to only
increase in growth due to the aging population. Out of all the various biomedical devices that are frequently used
in a clinical setting, urinary catheters are associated with the largest portion of medical complications related to
infection. Catheter associated urinary tract infections (CAUTIs) account for nearly 40% of all healthcare
associated infections (HAIs) and can lead to extended hospital stays for patients which in turn leads to higher
healthcare costs. To overcome this risk of infection, a catheter surface that is able to prevent bacterial adhesion
and biofilm formation while simultaneously eliminating planktonic bacteria present in the vicinity is highly
desirable. However, no long-term catheter solution has been able to accomplish this goal. Nytricx, Inc. has
developed proprietary methods and know-how developing anti-infective nitric oxide (NO) releasing interfaces
capable of effectively eliminating a wide variety of bacterial strains while being able to elicit no cytotoxic response
from mammalian cell lines. Nytricx, Inc. has also demonstrated that the liquid-infusion of silicone oil to create a
super slippery surface is able to prevent the adhesion of proteins and bacteria and thus eliminate biofilms. A
synergistic antimicrobial response is achieved by combining liquid-infused strategy and NO releasing polymers
(LINORel). The overall objective of this Phase I SBIR application is to create a long-term highly antimicrobial
urinary catheter through a combination of impregnating Foley catheters with a NO donor, S-nitroso-N-
acetylpenicillamine (SNAP), with a liquid-infused silicone oil interface and to evaluate commercialization
feasibility in terms of mechanical and biological properties.

Public health relevance
Narrative Urinary catheters are one of the most widely used medical devices in a hospital setting and are expected to only increase in growth due to the aging population. The overall objective of this Phase I SBIR application is to create a long-term highly antimicrobial urinary catheter through a combination of impregnating Foley catheters with a NO donor, S-nitroso-N-acetylpenicillamine (SNAP), with a liquid-infused silicone oil interface and to evaluate commercialization feasibility in terms of mechanical and biological properties.